Center of Biomedical Research Excellence in Acute Care Research and Rural Disparities - Equipment

Project Summary/Abstract.
The COBRE in Acute Care Research & Rural Disparities at Maine Medical Center, led by Dr. Douglas Sawyer,
is focused on mentoring acute care researchers, enhancing research infrastructure, and making a positive
impact on communities statewide. In its current Phase I, the program supports four project leaders in critical
areas such as post-resuscitation care, prophylactic antibiotics, molecular signaling studies, and telemedicine
for newborns. A significant part of this initiative involves the Flow Cytometry Core Facility at MaineHealth
Institute for Research, which houses our MACSQuant Analyzer-10 cytometer. With the system reaching the
end of its service life and facing increased usage, there is a crucial need to upgrade to the next generation
MACSQuant Analyzer-16. This advanced instrument offers six additional fluorescent channels, facilitating
simultaneous analysis of more extensive marker panels, which is vital for our researchers studying
stem/progenitor cells and immune cells. The instrument's enhanced capabilities align with the goals of the
COBRE and MaineHealth Institute for Research, supporting ongoing projects and expanding research
possibilities, including those led by COBRE project leaders. After a substantial $88,192 discount due to the
trade-in of the existing MACSQuant Analyzer-10, the total requested funds amount to $151,328. The
institutional support provided, including salaries, supply costs, and future service contracts, underscores the
vital role of the Flow Cytometry Core Facility in the success of the overall program. This investment is justified
by the critical role the Flow Cytometry Core plays in numerous impactful research projects, and the new
MACSQuant Analyzer-16 is expected to elevate the capabilities of the core facility, contributing significantly to
advancing scientific discoveries and supporting the goals of the parent grant.

Public health relevance
Narrative The COBRE in Acute Care Research & Rural Disparities at Maine Medical Center is seeking to upgrade the aging flow cytometer within the MaineHealth Institute for Research Flow Cytometry Core to the next-generation multicolor flow cytometer, crucial for advancing our research efforts. This upgrade is vital for achieving our objectives of mentoring acute care researchers, strengthening research infrastructure, and advancing our long- term goal of improving acute care outcomes for patients in rural areas.